Oregon Alzheimer's Disease Research Center

Project Summary: Overall
The overarching goal of the Oregon Alzheimer’s Disease Research Center (OADRC) is twofold: (1) to focus on
early detection of change in order to define mechanisms supporting healthy brain aging and the transition to
MCI and early dementia, and (2) to facilitate developing effective therapies to prevent or limit these transitions.
To achieve these objectives, eight cores and a Research Education Component are organized to catalyze and
sustain innovative research and discovery in Alzheimer Disease and related dementias (ADRD) through an
organizational infrastructure that supports a rich collaborative environment composed of leading edge
technologies and methods, multi-disciplinary scientists, empowered research volunteers, and an inspired
community of lay and professional stakeholders. The OADC provides the necessary materials to support
research through well-characterized research participants, biological specimens, brain tissue, data provision
and analytics. The OADRC focuses on specific areas of emphasis: 1) Preclinical dementia and activity of
disease emphasizing the oldest old; 2) Markers of meaningful change captured through studies of peripheral
biomarkers, neuroimaging and continuous in-home behavioral monitoring; 3) Neuropathology of brain aging
and late life dementia; 4) Novel testing of novel treatments, and 5) Improving education and sharing knowledge
about dementia.
To attain these goals and objectives, the OADRC Specific Aims are to:
1. Catalyze and sustain innovative research and discovery in Alzheimer Disease and related disorders through
an organizational infrastructure supporting a rich collaborative environment composed of leading edge
technologies and methods, multi-disciplinary scientists, empowered research volunteers, and an inspired
community of lay and professional stakeholders.
2. Focus the innovation and discovery infrastructure of the center toward specific areas of emphasis: (1)
Preclinical dementia and activity of disease emphasizing the oldest old; (2) Markers of meaningful change
captured through studies of peripheral biomarkers, neuroimaging and continuous in-home behavioral
monitoring; (3) Neuropathology of brain aging and late life dementia; (4) Novel testing of novel treatments;
and (5) Improving education and knowledge about dementia.
3. Provide the necessary materials to support the science through well-characterized research participants,
biological specimens, brain tissue, data provision and analytics.
4. Contribute to the national research commons relevant to Alzheimer’s disease and related disorders.
5. Provide venues and mechanisms for education and training of new scientists, as well as educating and
informing key stakeholders such as clinicians, patients and diverse family members to address the
challenges of dementia.

Public health relevance
Project Narrative: Overall The Oregon Alzheimer’s Disease Research Center creates a unique environment for research and discovery of new insights into healthy brain aging, transitions to Alzheimer’s, and for treatment and management of cognitive decline. This is facilitated by state-of the art clinical, biochemical, technological and statistical tools, subject and tissue resources, and data widely shared for maximum impact with the scientific community and appropriately translated to families and other key stakeholders.